ACTG 5051--INTERLEUKIN 2 COMBINATION W/ ANTIRETROVIRAL

To identify the gene(s) which predispose an individual to develop Parkinson's Disease. One Blood Sample of 40cc will be genetic tested and a questionnaire will be administered to the subject.